Administrative Core

Core A will provide logistics support for all other projects and cores. Regular group meetings will be coordinated through Core A. Many of the organizational elements have come into existence during the past year preparing for submission of the proposal, including regular group meetings where off-site members have joined via Skype, regularly scheduled face-to-face meetings coordinated with scientific conferences, and exchange of lab personnel. The Administrative Core will establish and maintain an interactive web-based platform to support communications among members via email, GoogleDocs, and Skype video conferencing. Interactions with the internal and external advisory boards will be coordinated through Core A. The Core will facilitate preparation and submission of abstracts and manuscripts, ensure timely submission of progress reports to NIH, and provide budgetary oversight for project expenditures. Purchasing, sample receiving and archiving, publications, and travel will be coordinated through Core A. This Core will monitor progress of each Project and Core, and will coordinate studies among investigators. The Core will manage the database, which will allow tracking and consolidation of all experimental data linked to each animal.